Pathogen-host interactions in Lyme disease interrogated at Single Cell Level

Lyme disease is the most common arthropod-borne illness in the US. Currently, there are no vaccines
available to prevent human Lyme disease and antibacterial therapy is the treatment of choice. Borrelia
burgdorferi, the agent of Lyme disease, is maintained in nature through an enzootic cycle involving a tick
vector and a variety of vertebrate hosts. B. burgdorferi undergoes extensive remodeling of its cell envelope in
response to environmental cues prevalent in these highly divergent hosts. The molecular interactions between
the borrelial envelope or its major determinants, such as peptidoglycan (PG) and surface-exposed lipoproteins,
with host cells play a critical role in the survival and infectivity of B. burgdorferi during different stages of its
infectious cycle. Moreover, B. burgdorferi is an extreme auxotroph lacking metabolic pathways for biosynthesis
of essential biomolecules and is therefore a highly host-adapted pathogen. In addition, the peptidoglycan (PG)
of B. burgdorferi has a unique composition with L-Ornithine as the branching amino acid in its pentapeptide
cross-linking the N-acetyl glucosamine and N-acetyl muramic acid polymers, which is distinct from the
pentapeptides present in the PG of Gram-negative and Gram-positive bacterial pathogens. Two mutants
strains of B. burgdorferi lacking Borrelia host-adaptation Regulator (BadR) or Borrelia host-adaptation Protein
(BadP) hyper- and hypo-express lipoproteins, respectively, serving as ideal genetic tools to interrogate
pathogen-host cell interactions mediated by differences in levels of surface-exposed lipoproteins. The long-
term objective of the proposed research is to disrupt the complex lifestyle of Lyme spirochetes within ticks and
mammalian hosts to reduce incidence of Lyme disease. In this proposal, we will test the central hypothesis that
remodeling of borrelial cell envelope alters host antimicrobial responses influencing survival of B. burgdorferi in
different hosts. The central hypothesis will be tested with two specific aims: Specific Aim 1: To determine
signaling effects of borrelial PG/lipoproteins on tick and mammalian cells using single cell RNA-Seq (scRNA-
Seq) analysis. Large arrays of transcriptional data will be analyzed and validated to identify pathways and
cellular phenotypes that distinguish response of single cells from transmission, reservoir and dead-end hosts
exploiting the advantages of using small numbers of host cells, spirochetes and minuscule levels of purified
borrelial determinants. Role of Peptidoglycan Recognition Proteins and Hippo signaling pathway in modulating
Bb infection will be interrogated. Specific Aim 2: To define effects of intact spirochetes defective in
PG/lipoprotein composition on primary host cells at single-cell level. Mutant spirochetes defective in PG
stability/synthesis or with altered levels of lipoproteins will be used to define their interactions with host cells
using RNA-Seq analysis and further validated for colonization capabilities using the experimental mouse
models of Lyme disease. The impact of this innovative study of pathogen-host interactions at single-cell level
will enable identification of novel signaling pathways critical for colonization/transmission of Lyme spirochetes.

Public health relevance
PUBLIC HEALTH RELEVANCE: Borrelia burgdorferi (Bb), the causative agent of Lyme disease, is classified as the most prevalent arthropod-borne infectious agent in the US. This pathogen causes significant morbidity and extensive health care costs in endemic areas where the disease is prevalent. Understanding how this pathogen is able to alter its adaptive capabilities and survive in widely divergent hosts is critical for developing novel strategies to reduce the incidence of Lyme disease.